Annual Conference of the International Society of Addiction Journal Editors: Preparing an underrepresented workforce for editorial board leadership

ABSTRACT/SUMMARY
The overall goal of this 5-year R13 grant is to address the substantial underrepresentation of knowledge
production and dissemination by individuals from underrepresented populations in addictions research. [For
the purposes of this application, underrepresented populations include: (a) individuals from underrepresented
and/or structurally minoritized racial and ethnic groups, individuals with disabilities, individuals from
disadvantaged backgrounds, and women; (b) individuals from low- and middle-income countries; and (c)
individuals from non-English-speaking countries.] This project will specifically increase the involvement of
individuals from underrepresented populations in the annual meetings of the International Society of Addiction
Journal Editors (ISAJE), an international society which was formed in 2001 to foster collaboration between
addiction journal editors globally. It serves editors, associate editors, reviewers and authors of addiction
journals and offers trainings and resources in addition to an annual meeting. Our long-term goal is to foster
increased participation of underrepresented populations in addiction journal publishing as editors. The current
project builds a foundation for this via proposing to support: (a) in-person attendance of editors from
underrepresented populations at each ISAJE meeting through a travel award; and (b) attendance of a
Keynote Speaker to deliver an address on a topic that is crucial for equity, diversity and inclusion in
addiction publishing at each ISAJE meeting. We will cover meeting attendance costs of five competitively-
selected editors from underrepresented populations including a Keynote Speaker selected from existing
addictions journal editors from underrepresented populations. Meetings over five years are planned to take
place both internationally and domestically in: Lisbon, Portugal, in 2024 (just prior to the Lisbon Addictions
conference); Seattle, USA (2025); Johannesburg, South Africa (2026); Montreal, Canada (2027); and Istanbul,
Turkey (2028). Our meeting will foster increased dissemination of science by and about underrepresented
populations, thereby addressing some of the bias in research published in addiction journals.

Public health relevance
NARRATIVE The publication of addiction science is highly skewed with underrepresentation in knowledge production and dissemination from people from underrepresented and minoritized population, individuals from low- and middle- income countries and people from non-English-speaking countries. The annual meeting of the International Society of Addiction Journal Editors (ISAJE) is an important forum where important knowledge about addiction science publishing is shared and developed. By being supported to attend the annual ISAJE meetings, increased numbers of editors from underrepresented populations will gain knowledge about addiction editing which will enhance the participation of underrepresented individuals in addiction production and dissemination in the long run.